Understanding the control mechanisms of 3D cell migration from new dimensions

Cell migration in 3D tissue space is of fundamental importance for human biology. However, predicting and
programming 3D cell motility remain as major challenges despite of a firm picture of the molecular machineries
involved. To fill the knowledge gap between the overwhelming subcellular details such as protein-protein
interactions, and the fascinating dynamic patterns exhibited by different cell types in tissue spaces, I will focus
on the mesoscale cellular dynamics, namely the migration mode transitions of cells in 3D extracellular matrix
(ECM). My lab has developed deep-learning based image postprocessing to track the migration modes of cells.
We also developed techniques to manipulate and measure the micromechanics of ECM at cellular scale. Based
on these preliminary results, I will systematically study the intrinsic and extrinsic control mechanisms of 3D cell
migration mode transitions in collagen ECM. The results will pave the way for my long-term goals to understand
the organizing principle that lead molecules to life, and to program cell motility for applications in tissue
engineering and cancer treatment. To this end, I will dedicate my lab to the following research thrusts. Thrust 1
aims to determine how cell migration mode transitions are regulated by external cues, as well as intrinsic states
of cells during the Epithelial-Mesenchymal Transition (EMT). I will test three hypotheses that elucidate the roles
of ECM micromechanical stiffness, anisotropy, plasticity, synergy of mechanical and chemical guidance, as well
as EMT stage in modulating the cell migration mode transitions. I will employ sophisticated ECM engineering
and characterization techniques developed in my lab. I will also use genetically engineered cells whose EMT
transcription factors are fluorescent labeled and can be specifically activated. Completion of thrust 1 will establish
3D cell migration as a hidden Markov process where the mesoscale dynamics, namely the migration mode
transitions, provides a unifying framework to explain diverse dynamic patterns of 3D cell migration observed in
vivo. Thrust 2 aims to devise strategies to program cell migration via nonstationary mechanical cues. In
subproject 1, I will employ techniques developed in my lab to control 3D contact guidance cues in space and in
real time. By measuring the migration mode transitions under step-increasing contact guidance, I will obtain the
energy barriers that separate different modes. Then under periodic mechanical stimuli I will measure and
computationally model the nonequilibrium mode transition flux, a statistical physics quantity that inform the
efficiency and energy dissipation of cell motility responses. These mesoscale quantities shed light to the
underlying molecular organizing principles. In subproject 2 I will develop collagen ECM which exhibits digital
response to stresses using DNA-grafted nanoparticles as crosslinkers. I will design the DNA sequence to control
the yield strength of crosslinkers, thereby programing cell migration mode both for single cell and for collective
organoid migration. Completion of thrust 2 will expands the design space of engineered ECM, laying a foundation
for the mechanical programing of 3D cell motility.

Public health relevance
3D cell migration is of fundamental importance for both normal physiological processes such as in development, and disease progression such as cancer metastasis. Understanding the regulation and control mechanisms not only will advance our basic understanding of how cells mechanically interact with their environment, but will also lead to powerful strategies to facilitate therapeutic strategies in areas such as tissue regeneration, immune disorder and cancer.